Preventing Tau uptake by novel inhibitors of tau binding to LRP1

PROJECT SUMMARY
Several neurodegenerative diseases, such as Alzheimer's disease (AD), are characterized by the spread and
aggregation of the protein tau. Tau aggregates or neurofibrillary tangles (NFTs) accumulate throughout the brain
of patients and lead to dementia. No effective treatments currently exist for tauopathies. Those approaches that
have been considered, such as tau antibodies and antisense oligonucleotides, directly target tau. The complexity
of tau cell biology, however, makes this approach challenging. A completely novel approach is to take advantage
of the tau spreading pathway. The spread of NFTs correlate with disease progression and is a likely mediator
for the observed neurotoxicity. Recently, we identified a cellular receptor, LRP1 (Low-density lipoprotein
Receptor-related Protein 1), that regulates the tau spread pathway. Knockdown of LRP1 prevents tau spread
in human iPS neurons and the mouse brain, suggesting that the tau-LRP1 interaction could be an important
entry point for disease intervention. Therefore, the main objective of this project is to identify small-molecule
chemical probes that prevent the binding of tau to LRP1, with the hypothesis that these molecules would serve
as key starting points for novel therapeutics. In preliminary work, we have identified the primary interaction
surface for tau on LRP1 and have developed a TR-FRET high-throughput screening (HTS) assay to identify
compounds that can disrupt this interaction. We have optimized the assay to 1536-well format and conducted a
pilot screen of 5,000 compounds with excellent performance, Z'~0.7 and a hit rate of ~0.4%. Analysis of the 20
hits from this screen in primary, artifact, and orthogonal assays identified several compounds with modest
potency in dose response. To fully develop this work, we propose three aims. In Aim 1, we will use the TR-FRET
assay to screen a 420,000 chemical library and, in parallel, conduct an affinity screen of a 4.4-billion-
member DNA encoded library leveraging the DELopen platform (WuXi AppTec). In Aim 2, we will narrow our hit
selection using orthogonal and novel biochemical profiling assays to determine mechanism of action. Finally, in
Aim 3 we will validate hits with advanced biophysical and cell-based assays. We expect our multi-pronged
approach will identify multiple chemical series with different mechanisms of action. Subsequent hit expansion
efforts will produce chemical probes with properties suitable to test our hypothesis that small molecule LRP1-tau
inhibitors can prevent tau uptake and spread. In future studies we intend to develop these probes into drugs that
prevent tau spreading in tauopathies such as AD. As the critical path testing funnel is in place, we anticipate we
can rapidly obtain and evaluate selective in vitro hits, explore their activity, and ultimately their suitability as
starting points for hit-to-lead studies and for future in vivo evaluation in animal models and eventually patients.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is a neurodegenerative disease representing the most common cause of dementia – affecting over 5 million Americans – and has no approved disease modifying treatments, which results in an enormous unmet medical need and burden on the healthcare system and society. Uptake and spreading of pathogenic Tau is recognized as a key driver of AD pathology, and is primarily mediated by tau's interaction with the cellular receptor LRP1. The goal of this application is: (1) to identify prototype drugs (chemical probes) that modulate the binding of Tau to LRP1; (2) to explore the activity of these probes in cellular systems to provide insight into the biology of this important receptor; and (3) to advance our long-term goal of developing a disease modifying treatment for Alzheimer's disease.